Research Education Component

ABSTRACT- RESEARCH EDUCATION COMPONENT
Research education has long been a core mission of the NYU ADRC and its affiliated Center for Cognitive
Neurology (CCN). Hence, we are pleased to expand our efforts with the formation of a new Research Education
Component (REC). The REC will build on the extensive experience of numerous NYU ADRC/CCN affiliated
researchers/clinicians and educators, who will nurture the careers of future AD/ADRD investigators. NYU
Langone Health (NYULH) is uniquely positioned to provide trainees with the resources needed to develop and
hone research skills by working in conjunction with world-class, established research programs and
internationally renowned mentors. Our program will take advantage of the NYU ADRC cores' long history of
training clinician scientists to become successful, productive investigators. We will recruit a scientifically and
demographically diverse group of up to five fellows named: NYU ADRC REC Scholars. The REC Scholars will
be given comprehensive mentoring and training, with funding for expenses such as travel to meetings and
exchanges with other ADRCs. A broad multidisciplinary training program will be developed, providing instruction
and training in cutting-edge research methods. A second group of REC Junior Scholars will be immersed in
the training program and will include NYU's diverse program for students led by the Sackler Institute, the Summer
Undergraduate Research Program (SURP). The REC specific aims are: Aim 1: Implement outreach, recruitment
and selection of a scientifically and demographically diverse group who will be leaders in AD/ADRD research.
We will select up to five individuals (REC Scholars) for an average of a two-year training period. Aim 2: Provide
broad multi-disciplinary training and mentoring. REC Scholars will be dually paired with experienced
investigators with clinical and/or basic research expertise. They will receive a comprehensive program of
didactics, training in statistical and epidemiological methods, scientific rigor, responsible conduct of research
training and career development. Each REC Scholar, with their mentors, will develop an individualized career
development plan. In addition to the REC Scholars, REC Junior Scholars will be identified each year from among
medical students, undergraduates, graduate students and residents at NYULH. Junior Scholars will participate
in didactic programs that focus on AD/ADRD and brain aging, and will each receive mentoring by a REC Scholar.
Aim 3: Augment inter- and cross-institutional partnerships to enhance research training in AD/ADRD. We will
work with the Neuroscience Institute, NYU's Clinical and Translational Science Institute (CTSI) and its clinical
research training, diverse NYU Colleges, other ADRCs, and Centers of Excellence in AD to provide REC
Scholars with opportunities for rotations to increase the breadth and depth of their training. Aim 4: Implement
methods for the measurement of the effectiveness of the NYU ADRC REC program, which will allow for
continued enhancement and refinement of our training mission.